OVARIAN HORMONAL EFFECTS ON OPIATE LEVELS IN ATHLETIC WOMEN

The primary objective of this proposal is to examine the interaction between opiate levels and ovarian steroid hormone levels in women athletes as a possible factor involved in the pathogenesis of exercise-induced amenorrhea. The present protocol is designed to manipulate ovarian steroid levels in highly trained amenorrheic and eumenorrheic runners and investigate the effects on beta endorphin levels.